Modeling fetal lung development in congenital diaphragmatic hernia

PROJECT SUMMARY/ABSTRACT
Congenital diaphragmatic hernia (CDH) is polygenic condition in which the fetal intestines and liver
herniate into the thoracic cavity, resulting in lung compression and impaired pulmonary development. Despite
being one of the most common and expensive surgical birth defects managed in neonatal intensive care units
worldwide, the underlying biomolecular mechanisms of CDH lung hypoplasia remain unknown. Advances in
state-of-the-art surgical critical care, including novel pharmacologic agents, extracorporeal membrane
oxygenation, and fetal surgery have failed to make a substantial impact in improving clinical outcomes in severely
affected children, with overall mortality remaining at 30%, largely due to the devastating degree of lung pathology.
There remains a critical need to better understand the mechanisms underlying CDH lung hypoplasia to offer
hope for affected patients and their families. YAP/TAZ is the core kinase of the Hippo signaling pathway that has
been shown to respond to mechanosensory stimuli during fetal lung patterning and differentiation. The proximal-
distal fetal lung abnormalities observed with the human CDH phenotype are consistent with those of YAP/TAZ
dysregulation in the setting of mechanical compression (reduced intrapulmonary pressures). Although
transpulmonary pressures have also been shown to regulate FGF10, an essential growth factor and major
downstream regulator of branching morphogenesis and epithelial differentiation, the interplay between the
YAP/TAZ translocation and FGF10-mediated lung growth in CDH is not well understood. The central hypothesis
of this proposal is that reduced nuclear YAP/TAZ activation during the canalicular stage of lung development
results in profound lung hypoplasia in CDH. Four research teams, led by Shaun Kunisaki (surgery), Jason
Spence (cell biology), Celeste Nelson (engineering), and Enid Neptune (pulmonary), will bring together
complementary backgrounds and technologies to address this hypothesis. Using the established nitrofen mouse
model, human lung organoids derived from induced pluripotent stem cells, and high throughput micro-
mechanical compression devices, three distinct aims are proposed. In Specific Aim 1, they will investigate the
impact of nuclear YAP/TAZ regulation during CDH canalicular lung development. In Specific Aim 2, they will
determine whether mechanical forces modulate CDH fetal lung morphogenesis ex vivo through YAP/TAZ
signaling. In Specific Aim 3, they will evaluate how nuclear YAP/TAZ activation affects in vivo lung growth in a
large animal fetal model of CDH. Completion of these Aims will have facilitated a better understanding of the role
of an important mechanosensing pathway during CDH lung development and will have potentially uncovered
new therapeutic targets for affected children at the more severe end of the CDH disease spectrum.

Public health relevance
Project Narrative The proposed project is relevant to public health because congenital diaphragmatic hernia (CDH) is a relatively common birth defect of the lungs associated with high mortality and morbidity. There remains a critical need to better understand CDH disease pathogenesis and to identify novel treatment options to improve the lives of affected children. The data generated from this proposal using rodent lung explants, human organoids, micro- mechanical technologies, and large animal models will enhance our understanding of the impact of a major mechanosensory pathway during the canalicular stage of fetal lung development.